Training Program in Endocrinology

PROJECT SUMMARY
The postdoctoral Training Program in Endocrinology at the Massachusetts General Hospital provides intensive
research experience in basic or clinical investigation, complemented by a didactic component appropriate to
the training goals. The trainees are primarily MDs and MD/PhDs who desire careers in investigative
endocrinology and academic medicine, as well as PhDs who want further research training. The trainees are
selected from a large applicant pool on the basis of prior academic and/or research achievement and evidence
of strong commitment to a career in biomedical investigation. The Program Director (K. Miller) and the
Associate Director (J. Florez) are senior Physician-Scientists who govern in conjunction with the Endocrine
Division Education Council, a committee of experienced endocrine scientists. The faculty consists of 42 active,
well-funded scientists, whose interests range broadly across the subdisciplines of endocrinology and from
clinical, bedside investigation to genetic and molecular mechanisms. The trainees are supervised closely by a
primary faculty mentor, and interact extensively with junior faculty, who often serve as co-mentors. In addition,
individual Scientific Advisory Committees provide ongoing scientific and career counsel. Internal and External
Advisory Committees provide evaluation and recommendations for Program improvement. Formal Program
and Mentorship trainee surveys and frequent (at least twice annual) one-on-one meetings between the
Program Director and trainees provide specific actionable input re: the Program and mentorship. An extensive
program of didactic sessions complements the research activity. This includes several weekly scientific series,
including Endocrine Grand Rounds, and a monthly Career Development didactic series designed for the
Training Grant trainees specifically. The productivity of past trainees during training has been very high overall,
as judged by the number and quality of trainee publications, number of trainees who obtain subsequent grants
and percent who remain in academia and the biotechnology/pharmaceutical industry. The facilities at the MGH
and Harvard Medical School are extensive, including a Division of Clinical Research, Harvard Catalyst Clinical
and Translational Science Center (CTSC) program and over 50,000 square feet of modern laboratories
dedicated to endocrine training faculty. This training grant is the central stabilizing financial element in this
program and is critical in enabling MD and MD/PhD trainees to achieve careers in biomedical investigation.

Public health relevance
PROJECT NARRATIVE The Training Program in Endocrinology at Massachusetts General Hospital (MGH)’s goal is to train MD, and MD-PhD physician scientists and PhD scientists in clinical and/or laboratory research related to endocrinology, diabetes, metabolism and allied fields. The public health burden of endocrine diseases (such as diabetes and its complications, obesity and osteoporosis) and its associated societal costs are enormous, and therefore there is an urgent need to train and enable the best and brightest individuals considering careers in biomedical investigation to deploy contemporary experimental methods that will generate insights into this set of disorders, elucidate their pathophysiology, and illuminate potential avenues for treatment. With these goals in mind, the MGH Training Program in Endocrinology has produced a large number of endocrine investigators over the years, many of whom have become authentic leaders in science, academia and industry.